IV ALATROFLOXACIN FOR TREATMENT OF COMPLICATED INTRAABDOMINAL INFECTI

This study will compare the role of sequential therapy with intravenous alatrofloxacin and oral trovafloxacin as empiric monotherapy for the treatment of complicaled intra-abdominal infections in hospitalized patients.